DEVELOPMENTAL SYNAPTOPATHIES ASSOCIATED WITH TSC, PTEN, SHANKS MUTATIONS

The Developmental Synaptopathies Consortium (DSC) Administrative Unit will facilitate the collaboration and communication of clinical research in the rare diseases of TSC, PTEN and PMS across the ten participating sites. The Administrative Unit will ensure collaboration among Project Leaders, Principal Investigators, and site study staff for the longitudinal research in each of the three identified diseases, the training component, the clinical pilot studies, and the access to information related to the rare diseases for basic and clinical researchers, other health professionals and the public.

Public health relevance
The Administrative Unit provides the key framework for success collaboration amongst the investigators involved in this Consortium. The Unit will ensure that research is conducted uniformly across all sites. It will be responsible for creating budgets and allocating funds in a rational, fair and appropriate manner. It will create policies and procedures related to all aspects of the studies, including the pilot projects and the training component.